Connectome-based neuromarkers of problem cannabis use

Project Summary/Abstract
Insufficient knowledge of brain-based risk factors for problem cannabis use is a key barrier to identifying
individuals at risk for cannabis-related harm and designing targeted prevention and early intervention
approaches to promote positive development for persons at risk. The current proposal combines multiple, large-
scale, neuroimaging datasets with novel densely-sampled fMRI data to identify a neuromarker of problem
cannabis use and characterize its development prior to cannabis use onset, and in the context of current
cannabis use in adolescence. We will apply a whole-brain, machine-learning method – connectome-based
predictive modeling – to identify a neural network predictive of problem cannabis use in a large sample of college
students (Brain and Alcohol Research in College Students study; BARCS), and compare this network to
canonical neural networks previously implicated in risk for cannabis use: frontoparietal, salience, and default
mode networks. We will then examine the developmental trajectory of these cannabis risk networks in relation
to other known risk factors for addiction prior to cannabis use onset in the Adolescent Brain Cognitive
Development (ABCD) dataset, a nationally-representative sample of 11,875 children. We will examine whether
individuals at high-risk for substance use problems (family history of substance use and exposure to early
adversity) display a delay in the typical trajectory of network stabilization within cannabis risk networks. Finally,
we will collect densely-sampled fMRI data (4 scans in 6 months) from 20 adolescents (age 15-17) who regularly
use cannabis and 20 age- and sex-matched typically-developing adolescents. This study design will enable us
to examine cannabis effects on short-term neural network dynamics and evaluate whether cannabis using
adolescents are characterized by reduced stability of cannabis risk networks relative to their typically-developing
peers. By combining multiple existing large-scale neuroimaging datasets with original, longitudinal, densely-
sampled fMRI data, the proposed study design offers a unique opportunity to examine the interplay between
neural mechanisms of risk for problem use and cannabis exposure effects on the developing adolescent brain
and promises to yield important insights into the neural mechanisms of risk for problem cannabis use that can
foster novel prevention and intervention initiatives to mitigate cannabis-related harms for individuals at high risk.
The current proposal also aims to provide Dr. Sarah Lichenstein with expert mentorship by Drs. Pearlson,
Casey, Yip, Scheinost and Stevens to build the skills necessary to develop into an independent clinical scientist
applying multimodal neuroimaging methods to study the pathophysiology of addiction. Dr. Lichenstein will pursue
specialized training in studying cannabis effects on brain and behavior, big data science, and the conduct of
research with adolescent participants. Furthermore, the collection of novel, densely-sampled, adolescent fMRI
data will also provide Dr. Lichenstein with a rich and unique pilot dataset to support the submission of a R01
application by the end of the award period and facilitate her transition to an independent investigator.

Public health relevance
Project Narrative Cannabis use is extremely common and associated with clinically-significant negative outcomes for a subset of users, yet it is not currently possible to predict who is at highest risk for cannabis-related harms at the individual level. The current proposal aims to identify a neural network predictive of problem cannabis use, and to characterize the development of this network both before and after cannabis use onset. Elucidating the neural basis of problem cannabis use will facilitate the development of novel prevention and early intervention efforts to mitigate potential cannabis-related harms for individuals at highest risk.